Administrative Core

Administrative Core: Project Summary
The overarching goal of the UPSTREAM Research Center Administrative Core is to provide the administrative
support necessary to direct research activities through a cohesive, integrated, and efficient Center that will
serve as a critical hub and resource for participating institutions, community partners, and the national network
of persistent poverty centers. The Administrative Core will bring together a coalition with unparalleled
resources and reach, and coordinate activities across multiple institutional and community partners:
the Comprehensive Cancer Centers of Stanford University, the University of California, San Francisco (UCSF)
and the University of California, Davis (UCD); The UCD Center for Advancing Cancer Health Equity; The
Stanford Center for Poverty and Inequality; Stanford Basic Income Lab; state and local governments; and
community-based organizations. The Administrative Core will help build research capacity in areas of
persistent poverty, support community-engaged research and develop capacity for implementing multi-level
and multi-factorial cancer prevention and control interventions that include basic income interventions. As the
hub for the management and coordination of all Center activities, the Administrative Core will create synergy
within the Center and across the national network of persistent poverty centers. We will maximize efficiency,
cost-effectiveness, and productivity by centralizing common administrative and operational resources. The
goals of the center and the means of achieving those goals will be guided by a Regional Coalition of
Community Partners who will play an active role in the functioning of the administrative Core and the overall
center. Dr. Melissa Bondy, Professor and Chair of the Department of Epidemiology and Population Health at
Stanford University and Associate Director for Population Health at the Stanford Cancer Institute (SCI) will lead
the Administrative Core, supported by Dr. David Rehkopf (Stanford), Dr. David Grusky (Stanford), Dr. Robert
A. Hiatt (UCSF), and Dr. Luis G. Carvajal-Carmona (UCD), and Project and Core leaders, and the regional
coalition on a Center Executive Committee (EC). The Administrative Core will convene weekly meetings,
monthly full meetings, monthly Executive Committee meetings, and an annual retreat to foster collaboration
and synergy. Day-to-day operations of the Administrative Core will be overseen by a dedicated Center
Manager. The Administrative Core has the following Specific Aims: 1) Provide administrative leadership and
integration of Projects and Cores across the proposed Center 2) Convene internal and external advisory board
meetings and facilitate meaningful interactions between advisory boards, Center members, the regional
coalition of community partners and other persistent poverty centers. 3) Develop a diverse, transdisciplinary
research workforce. 4) Build research capacity in persistent poverty areas and provide infrastructure for
collaborative studies with community partners. 5) Establish practices to monitor Project productivity and assess
use of Core resources. 6) Coordinate and implement broad results dissemination.